Fostering Research Mentorship & Training during Psychiatry Residency Supplement

Project Summary:
There has been a significant decline in the number of research psychiatrists and research fellowships for
psychiatrists in the past two decades (Fenton et al. 2004, Pincus et al. 2005). Moreover, the number of under-
represented minorities—those of minority racial and ethnic backgrounds, and those possessing disabilities—
who dedicate themselves to psychiatric research has been limited. Exposure to research prior to entering
residency with careful and dedicated mentorship can help overcome this limitation. Here we propose to
continue a program to provide a supported, mentored research opportunity to under- represented minorities
during their training in medical school. Such training (a) promotes research literacy and inclusivity for all
trainees, (b) encourages future participation of clinicians as research collaborators, (c) provides experience
that can foster choosing a research career, (d) expands clinical knowledge through the formulation of patient-
oriented research questions, (e) attracts diverse medical students into psychiatry training, and (f) maintains
and facilitates research interest among residents with and without investigative backgrounds (IOM 2003). The
Physician-Scientist Training Program (PSTP) at the Massachusetts General Hospital (MGH) Department of
Psychiatry and McLean Hospital within the residency training program was developed to fill this need, and this
administrative supplement directly addresses the issue of diversity of trainees. The goal of the PSTP is to
prepare residents for careers as investigators in academic psychiatry by facilitating greater exposure to
research activities and training during residency. Through its federally funded period, the PSTP has been
successful in attracting and recruiting talented psychiatrist-scientists and has developed an effective research
education program with appropriate infrastructure that has attracted clinician-scientists to careers in psychiatry
and provided them both mentorship and research experience to prepare them for an independent investigator
career in psychiatry and neuroscience following residency. With this supplement we will expand this
opportunity to attract first year medical students from underrepresented in medicine (URM) backgrounds and
introduce them to research training in psychiatry. The administrative supplement proposal will additionally allow
us to (1) train 3 URM students in research literacy and methodology of clinical and translational psychiatric
research through coordinated educational seminars and hands-on research mentorship and (2) include these 3
students in our community of psychiatrist-scientist trainees and mentors to expand their interests and
understanding of the opportunities available for future training in psychiatry.

Public health relevance
Project Narrative In 2007, the Massachusetts General Hospital (MGH) and McLean Hospital piloted an integrated Research Concentration within the MGH/McLean Adult Psychiatry Residency Training Program to address the critical shortage of physician-scientists engaged in mental health research careers. This now established program, funded by the NIMH R25 mechanism since 2011, has been highly successful. This administrative supplement application will provide support and infrastructure to continue, improve, and expand this well-integrated research education program by supporting underrepresented in medicine minority students to expand our capacity to attract and train a more diverse group of future psychiatrist-scientists in basic, translational, and patient-oriented research, while increasing research literacy and inclusivity among all psychiatry residents.